TRIAL OF REPEATED DOSES OF LJP 394 IN PATIENTS WITH SYSTEMIC LUPUS ERYTHMATOSUS

The purpose of this study is to determine whether LJP 394 is more effective than placebo in preventing renal flare in patients with a prior history of lupus renal disease. This multicenter, double-blind, randomized, placebo- controlled study will enrol approximately 400 patients and is composed of three periods: a screening/qualifying period, a double-blind, placebo- controlled treatment period, and a follow-up assessment period. This is an 18 month trial, with patients completing 61 visits.